Quantitative Social Phenotyping in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Dr. Joel Salinas is a Behavioral Neurologist and Neuropsychiatrist at Massachusetts General Hospital (MGH),
whose career goal is to become a leading clinician-investigator in the field of brain aging with specific emphasis
in understanding the socio-behavioral aspects of Alzheimer's disease (AD). These insights will help identify
underlying biological pathways in AD risk and disease progression and, eventually, characterize more patient-
centered interventions and outcomes in the treatment of AD. As a first step towards this goal, he seeks to
improve the study of social relationship factors in AD by developing effective methods for quantifying and
identifying relevant social phenotypes. This area of AD research is promising because factors like loneliness and
social isolation have been tied to accumulation of AD-related neuropathology, but the biological underpinnings of
these influences remain poorly understood. A critical barrier to improving our understanding of these pathways is
addressing the complexity of social relationship factors and temporally relating these to biological changes and
disease risk. To overcome this barrier, Dr. Salinas's proposal seeks to use a large, well-characterized,
community-based longitudinal cohort to investigate whether social relationship factors—when quantified at the
level of two major subcomponents, social support and social network graphs—1) prospectively affect risk for
incident AD and 2) are associated with vulnerability for AD-related neurodegeneration and cognitive decline. Dr.
Salinas plans to employ a research approach that systematically relates social phenotypes to neuropsychological
testing, cutting-edge neuroimaging, and clinical assessments most relevant in the earliest stages of AD. Dr.
Salinas established an early-career track record in the investigation of neuroimaging markers of development as
well as the psychosocial determinants and epidemiology of poststroke depression, acquiring foundational
expertise in statistics and bioinformatics in the process. As part of a mentored T32 award, he also generated
preliminary data supporting the feasibility of the proposed research. The proposed K23 award will train Dr.
Salinas in selection, capture, and interpretation of social relationship measures, social network graph model
construction and analysis, and advanced techniques in the medical epidemiology of aging. To this end, Dr.
Salinas has assembled a team of experts in all aforementioned areas, leveraging the extensive resources and
exceptional environment of Massachusetts General Hospital, Harvard Medical School, Harvard TH Chan School
of Public Health, Boston University School of Medicine, and the Framingham Study networks. Dr. Sudha
Seshadri will serve as primary mentor with Dr. Jonathan Rosand as co-mentor alongside an advisory committee
of highly experienced members, including Drs. Lisa Berkman, Charles DeCarli, JP Onnela, and Reisa Sperling.
This award will provide Dr. Salinas with the skills to evolve into an independent clinician-investigator at the
forefront of AD quantitative social phenotyping, developing methods that may ultimately enhance AD research in
observational cohorts and clinical trials.

Public health relevance
PROJECT NARRATIVE / RELEVANCE No biological risk factors completely explain observed trends in Alzheimer’s disease incidence, though emerging evidence implicates social relationship influences with accumulation of Alzheimer’s disease pathology. The full biological role of these potentially modifiable influences in Alzheimer’s disease risk and related brain changes remains unclear—likely due to the! current lack of developed quantitative social phenotyping methods in Alzheimer’s disease to address the full complexity of social relationship factors. Dr. Salinas’s proposed career development plan and research strategy hold great promise in advancing our understanding of social relationship factors in Alzheimer’s disease and represent a crucial step towards harnessing these insights for better strategies in preserving brain health.